Davoli/Camacho-Hernandez Diversity Supplement

Summary of the funded parent grant
Aneuploidy—the presence of chromosome gains and losses—is very rare in normal tissues but occurs in more
than 80% of human tumors, especially in solid tumors. A high level of aneuploidy in tumors correlates with higher-
grade disease, tumor progression, and resistance to therapy. Whether and how aneuploidy contributes to
formation and progression of human tumors is not well understood. Whereas genomic and clinical studies in
cancer patients suggest that aneuploidy drives tumorigenesis, experimental studies in mouse models and in vitro
systems has so far yielded conflicting data on the role of aneuploidy in tumors. Human tumors are often
specifically associated with either increases or decreases in the number of specific chromosome(s). One of the
main obstacles to progress has been the technical limitation of not being able to engineer the ‘right’ type of
aneuploidy in the ‘right’ cell type.
Our ultimate goal is to dissect whether and how aneuploidy contributes to initiation and progression or
human tumors. Our first objective here is to generate cellular models that faithfully recapitulate the aneuploidy
patterns found in tumors in order to study how aneuploidy affects the pathobiology of tumor cells (their ability to
grow in vitro or in vivo, to evade cell death pathways, to survive cellular stress and to regulate transcription and
translation). Our second objective is to uncover vulnerabilities and synthetic lethal interactions potentially
associated with the aneuploid state. The outcomes of the proposed project will represent the foundation to
achieve the long-term goal of our lab, which is to develop a better understanding of the causes and
consequences of aneuploidy in human tumors in order to uncover aneuploidy-associated biomarkers and
therapeutic targets.
To accomplish this goal, we will first use a panel of newly generated human cells containing different
degrees and types of aneuploidy to compare diploid and aneuploid cells for several tumor-related cellular
phenotypes both in vitro and in vivo. Secondly, we will adopt a systematic approach to identify genes and
pathways that when blocked, inhibit proliferation and survival of aneuploid tumor cells but not normal cells. Third,
we will perform a protein and phospho-protein analysis mainly of colorectal tumor patients’ samples to dissect
the consequences of aneuploidy at the level of protein stability and pathway regulation. Our results will fill an
important gap of knowledge in our current understanding of how aneuploidy evolves during tumorigenesis and
how we might take advantage of this knowledge to improve patient outcomes.

Public health relevance
Project Narrative Aneuploidy is very frequent in cancer but its role in tumorigenesis and as a potential target for cancer therapy is poorly understood. Within the scope of the funded parent grant, this application aims at performing computational analyses on existing data on colorectal cancer patients to better define the cancer driver genes located on chromosome 7 and at validating experimentally these predictions. The other main goal of this application is to foster scientific and educational training for Elaine Camacho-Hernandez to promote her future academic career.